Tackling Big Data problems in biomedical sciences with extended similarity methods

N

Public health relevance
PROJECT NARRATIVE Big Data problems are ubiquitous in biomedical research, but current methodologies based on pair-wise similarity calculations are too computationally expensive, so they are ill-equipped to handle the amount of data generated by state-of-the-art simulations and experiments. We seek to develop, implement, and apply novel highly-efficient computational techniques tailored for large-data applications based on our extended similarity framework. This will lead to more general and robust drug design protocols, a better understanding of complex biological processes (including protein folding and structure determination), and versatile ways to process mass spectrometry images of diverse tissues, leading to new insights in pathophysiology and novel diagnosis tools.